Chronic Mental Health: Improving Outcomes through Ambulatory Care Coordination

DESCRIPTION (Provided by Applicant): Appropriate and timely care coordination contributes significantly to improved behavioral health outcomes for patients with chronic mental illness. This project will demonstrate how health information exchange between rural and urban providers can improve ambulatory patient care coordination and safety across treatment settings. Currently, without electronic communication, behavioral health providers are unable to follow the entire treatment path of patients from mental hospitals, protective custody, or crisis mental health holds to various providers in the urban or rural community settings. Waiting for services or medication adjustments increases the problems faced by people with chronic mental illness. Health information technology is believed to be critical for efficient implementation of behavioral health chronic care models. Increasing safety and enhancing quality of treatment for mentally ill patients in southeast Nebraska will be achieved through the development and implementation of a Health Information Exchange (HIE) for the region. An HIE will create timely access to patient information between and among the provider care team serving an individual with a mental illness. This, in turn, will improve the continuum of care by providing basic electronic information to coordinate patient care between behavioral health providers, primary care physicians, rural hospitals, and the emergency behavioral health system that will improve the long-term health outcomes of individuals with mental illness. Little is known about how health information exchange among behavioral health providers improves care coordination, particularly for patients transitioning between inpatient and outpatient settings. This project will contribute to knowledge of behavioral health information exchange through three studies: * Provider barriers to technology acceptance in the behavioral health setting; * Behavioral healthcare technology acceptance and adoption;and * Impact of health information exchange on clinical outcomes. This formative and summative research plan explores pre-conceived barriers, intention to adopt, actual adoption, and clinical outcomes.

Public health relevance
PROJECT NARRATIVE Chronic Mental Health: Improving Outcomes through Ambulatory Care Coordination Little is known how health information exchange among behavioral health providers improves care coordination, particularly for patients transitioning between inpatient and outpatient settings. This project will contribute to knowledge of behavioral health information exchange through three studies: 1) Provider barriers to technology acceptance in the behavioral health setting; 2) Behavioral healthcare technology acceptance and adoption; 3) Impact of health information exchange on clinical outcomes. This formative and summative research plan explores pre-conceived barriers, intention to adopt, actual adoption, and clinical outcomes for chronically mentally ill consumers.